Managing Perioperative Pain with Abdominal Laparoscopic Surgery: A Collaborative to Develop, Disseminate, and Evaluate Evidence-Based Practices (M-PALS Collaborative)

Project Summary/Abstract:
Dependence on prescription opioids is a public health crisis affecting millions of people in the U.S. Evidence-
based clinical guidance is critical for managing pain while reducing the risk of opioid use disorder (OUD), but
there is a lack of guidance for managing acute pain associated with abdominal laparoscopic (including robotic)
surgeries, which is the preferred and growing technique for a vast number of abdominal surgeries (e.g.
cholecystectomy, bowel obstruction, appendectomy, colon and rectal surgery, etc.). The project, Managing
Perioperative Pain After Abdominal Laparoscopic Surgery: A Collaborative to Develop, Disseminate, and
Evaluate Evidence-Based Practices (M-PALS Collaborative) will develop a clinical-practice guideline (CPG)
with interdisciplinary stakeholders and subject matter experts, and then translate and evaluate this CPG in
practice. We hypothesize this up-to-date and comprehensive CPG and subsequent implementation and
dissemination will result in superior pain management and minimized use of opioids, as well as decreased
rates of OUD after abdominal laparoscopic surgery (especially in opiate naive patients), and similarly improved
patient satisfaction and pain management metrics. To account for variability by region and differences in
surgical workflow by practice setting, we ensure broad applicability by conducting our work at M Health
Fairview (UMN, a collaboration of the UMN Medical School, Univ of MN Physicians, and Fairview Health
Services) and the University of California, San Francisco across distinct and diverse patient populations. Aim
1: In collaboration with the FDA and guided by MN-EPC, develop a laparoscopic abdominal surgical pain
management CPG. We will leverage and extend the National Academy of Sciences, Engineering, and
Medicine (NASEM) framework on acute pain management, convene multidisciplinary expert stakeholders, and
guide CPG development to address abdominal laparoscopic surgical populations and perspectives on unmet
needs, including disparities in pain management. Aim 2: Implement and disseminate the CPG. Core activities
cover CPG acceptance, academic dissemination, website materials, LHS learning communities to
enhance/scale, EHR tool CPG implementation (including CDS) via a stepped-wedge design, and an
EHR-vendor clinical program to share tools across organizations. Aim 3: Evaluate and assess the CPG
including adoption, feedback on facilitators and barriers, and outcomes. Assess primary (CPG adherence, pain
scores, opioid use) and secondary outcomes guided by RE-AIM; evaluate implementation (e.g., study
strategies, system factors, stakeholder engagement) guided by EPIS. This project is significant, innovative,
and feasible, applying rigorous CPG development, extending NASEM report frameworks, utilizing novel LHS
approaches in CPG implementation, and leveraging a transdisciplinary expert team with a track record of
successful collaboration and health system-embedded research.

Public health relevance
Project Narrative: The project will generate, implement, and share a clinical practice guideline to help clinical teams manage pain in preparation for, during, and after abdominal laparoscopic surgery. Optimal and comprehensive pain management can minimize prescribing of opioid analgesia and will ensure pain management without unnecessary opiate exposure and adverse effects.